PALLIDOTOMY IN PARKINSONS DISEASE: DIGITIZING MASKED FACE

The purpose of this study is to better understand how those brain regions that are affected by Parkinson's disease contribute to different aspects and types of facial expressions.